Data Collection, Linkages, Cleaning and Sharing Core

ABSTRACT: Data Collection, Linkages, Cleaning, and Sharing Core
The National Dementia Workforce Study (NDWS) will be launched by a national team of experts in clinical care
of persons living with dementia, survey research, and health workforce research. The goal of the NDWS data
infrastructure is to allow researchers and policymakers to ask and answer scientific questions to help build the
workforce of clinicians and other professional care providers required by the growing population of persons
living with dementia in the U.S. As required by this cooperative agreement, the Data Collection, Linkages,
Cleaning, and Sharing Core will oversee a competitive bid process to select the organization(s) that will be
responsible for fielding the NDWS surveys designed by the Screening and Survey Instrument Development
Core. This Core will then be responsible for management and oversight of the survey vendor(s) to ensure
comprehensive and consistent data definitions and standardization across the four NDWS surveys, including
quality control of the data produced. In addition, as a supplemental data collection activity, a subset of
respondents and institutional representatives from each of the four surveys will be selected for qualitative data
collection in order to provide a rich additional data source that will be available for linkage with the NDWS
survey data.